Bright and switchable fluorophores for highly multiplexed super-resolution microscopy towards molecular interaction imaging

PROJECT SUMMARY
Super-resolution imaging has been a revolutionary technique for biomedical sciences and provided invaluable
information about cellular architecture and function at the molecular level with nanometer precision. However,
the multiplexing capability and spatial resolution are mainly constrained by the performance of existing
fluorescent labels. We propose to develop a palette of bright and switchable fluorescent dyes, referred to as
SwitFluor, for multiplexing super-resolution imaging method to simultaneously resolve 6 molecular targets at
10-nm spatial resolution within 10 minutes. We aim to concurrently (1) achieve ultrahigh photon emission rate
during the bright state of single-molecule switching process using a newly designed enhancer strand in DNA
point accumulation for imaging in nanoscale topography (DNA-PAINT) dye system, and (2) simultaneously
switch fluorescence of 6 specially designed spectrally-distinct SwitFluor dyes using orthogonal imager strands
for simultaneous imaging with our recently developed spectroscopic single-molecule localization microscopy
(sSMLM) optical system. The integration of bright SwitFluor (DNA-PAINT) dyes with sSMLM will collectively
achieve the proposed goal. The proposed technology could make a profound impact on a wide range of
biological research as we will be able to study complex cellular processes deep down to the molecular scale.

Public health relevance
PROJECT NARRATIVE This project aims to develop a palette of bright switchable fluorescent probes for simultaneous multiplexed super-resolution imaging at the molecular level. We will increase the photon emission rate of the newly-designed switchable dyes and encode distinct spectral features of the switchable dyes in the two specific aims to collectively provide high resolution and multiplexity. This project will allow biomedical researchers, for the first time, to achieve simultaneous multi-color imaging of 6 molecular labels at 10-nm spatial resolution within 10 minutes. System performance will be investigated by imaging nanoscale engineered samples, and multiple molecular targets with distinct morphologies in cells.